UCSF Dermatology Training Grant

Project Summary/Abstract
The Dermatology Department at the University of California, San Francisco, has a long tradition of training
promising young scientists to be successful, independent investigators. The UCSF Dermatology Training
Program encourages physician scientist trainees to pursue cutting edge research in any laboratory at the
university. This allows the trainees to choose from all the outstanding UC faculty, regardless of their
departmental affiliation. With the recent expansion to the Mission Bay Campus, UCSF has added a significant
amount of research space, has recruited numerous new faculty members, and will continue to do so to take
advantage of the new space being made available. The UCSF Dermatology Department has also expanded
over the last 5 years in terms of research space, the number of faculty conducting basic and translational
research, and the number of residents and fellows. Building on our successes in the past and capitalizing on
the UCSF expansion, we propose to adjust our training program slightly to include physician-scientists whose
interests are focused on patient-oriented research. With this updated mission, the UCSF dermatology training
program prepares physicians and Ph.D. scientists for a lifetime of scholarly pursuits with the ultimate goal of
understanding the molecular basis of skin diseases, finding new therapies for these diseases, and ensuring
that scientific discoveries lead to advances in public health in an equitable and cost-effective manner. Our two-
fold goals of exposing our physician scientist trainees to the rich scientific and clinical research milieu at UCSF
and of recruiting Ph.D. scientists to study skin biology in the department will ensure that a cadre of young
scientists will pursue academic careers in dermatological research and advance the field in fundamental ways.

Public health relevance
Project Narrative The UCSF Dermatology Training Program encourages physician scientist trainees to pursue cutting edge research and prepares them for a life-time of scholarly pursuits with the ultimate goal of understanding the molecular basis of skin diseases, finding new therapies for these diseases, and ensuring that scientific discoveries lead to advances in public health in an equitable and cost-effective manner.